The Role of Negative Effort Dependence as a Targetable Mechanism of Upper Airway Collapse in Sleep Disordered Breathing

This proposal outlines a 5-year research and career development plan for Dr. Brandon Nokes, director of
Hypoglossal Nerve Stimulation at VA San Diego and a pulmonary/critical care physician at UCSD. The major
objective of his research is deriving mechanistic understanding of within and across-breath negative effort
dependence, common and important subtypes of flow limitation in obstructive sleep apnea (OSA). This CDA-2
proposal outlines and provides support for his career development plan, specifically focusing on Training Aim
(TA)1, upper airway physiology and control of breathing, TA2, physiological signal processing, TA3, clinical trial
design and appropriate statistics. Dr. Nokes has assembled a diverse team of collaborative experts to support
his career development and mentor him consisting of Dr. Atul Malhotra, an internationally recognized expert in
upper airway physiology with Dr. Owens, Chair-Elect of the Sleep and Respiratory Neurobiology (SRN)
Assembly at ATS, as well as Dr. Crotty-Alexander, Section head of Pulmonary/Critical Care of VA San Diego
and recipient of CDA-2 and MERIT funding pertaining to respiratory science. Additionally, his training team
includes experts in upper respiratory physiology (Dr. Powell and Dr. Spragg), fluid mechanics and signal
processing in the upper airway (Dr. Butler), and upper airway electrical stimulation (Dr. Strollo), as well as an
expert in clinical trial design and biostatistics (Dr. Sonia Jain). Despite the significant clinical burden of
obstructive sleep apnea in Veterans (the most common service-connected respiratory condition), continuous
positive airway pressure (CPAP) use is historically poor. Current approaches to OSA care emphasize “one-
size fits all” approach with CPAP being the gold-standard. However, it is now understood that there are
multiple physiologic traits (endotypes) which may be amenable to tailored therapies beyond CPAP alone. The
PI will evaluate the role of negative pressure reflexes in within-breath negative effort dependence in Aim 1.
Prior investigations assessing negative pressure reflexes are well-validated and the PI is well-trained to identify
NED as well as conduct physiology-based polysomnography (including genioglossus electromyography and
epiglottic pressure catheter placement). However, whether reflex attenuation creates a risk for within-breath
NED has yet to be established. Aim 2 will assess the role of an imbalance in respiratory drive between the
upper airway and thoracic pump mechanistically underly across-breath NED. Both of these modes are flow
limitation are especially important as the only way to terminate these breathing events is through arousal,
leading to sleep fragmentation and potentially adverse neurocognitive and cardiac outcomes. This work will lay
the groundwork for future MERIT studies focused on individualizing OSA treatments. This work will also help to
build the San Diego VA Sleep lab into a world class physiology-tailored sleep lab. The research and career
development plan affords Dr. Nokes an impressive foundation to develop into a prominent clinician-scientist
working to improve care by developing and implementing novel approaches to Veteran sleep care. Dr. Nokes
is fully committed to improving the care of Veterans with OSA by providing individualized sleep care based on
individual physiology.

Public health relevance
Obstructive sleep apnea (OSA) is the most prevalent service-connected disability of all the respiratory disabilities for which Veterans receive benefits. Between 2015-2018, OSA burden has increased from 664,000 to 1.3 million Veterans, generating nearly $234 million in sleep apnea supply cost, despite fewer than 50% of Veterans using continuous positive airway pressure (CPAP) devices as prescribed. There are multiple mechanisms underlying sleep apnea pathogenesis, each of which may be amenable to tailored treatment beyond CPAP alone. The purpose of this proposal will be to identify the mechanisms underlying an understudied mode of pharyngeal collapse called negative effort dependence. This work will pave a path towards individualized Veteran sleep care based on individual physiology.